Interrogating the role of reactive astrocytes during Toxoplasma-induced brain inflammation

PROJECT SUMMARY
Toxoplasma gondii is a common protozoan parasite that forms a lifelong infection in the brain. Despite
chronic infection, Toxoplasma only causes clinical pathology in the immune compromised and therefore
triggers an effective and well-balanced immune response in the brain. T. gondii replication and innate
immunity are strongly regulated by CNS resident astrocytes. Astrocytes ordinarily execute vital processes
for proper brain function and reprogram into reactive astrocytes (RAs) during brain inflammation. The
beneficial or detrimental roles of RAs in brain inflammation and neurotoxicity has remained debated and
largely unknown. During Toxoplasma infection, astrocytes limit parasite proliferation in a STAT1-depend-
ent manner, produce multiple cytokines and chemokines to attract immune cells to the brain, and modify
extracellular concentrations of neurotransmitters to regulate the inflammatory environment of the tissue
Like many immune cells, astrocytes are increasingly recognized as falling into distinct functional subsets
but unlike immune cells our ability to manipulate RAs or study their function in a disease- or infection-
specific manner has been limited. Here we propose to characterize, track and selectively manipulate RAs
to determine their diversity and functional roles in the immune response during chronic Toxoplasma in-
fection. We have generated a novel tamoxifen-inducible Cre knock-in mouse line driven by the lipocalin
2 (Lcn2) promoter (Lcn2CreERT2). By crossing to the Ai9 TdTomato reporter line, we have visualized RAs
in various pathological states including systemic inflammation and T. gondii infection. Traditional astro-
cyte promoters will be used in combination with Lcn2CreERT2 to selectively target RAs for genetic manipu-
lation at any point during progression of infection, while leaving healthy astrocytes, neurons, and other
glial cell types intact, transforming our understanding of astrocyte function and underlying inflammatory
mechanisms during Toxoplasma infection. Three aims are proposed: In Aim1 infection-induced astrocyte
subsets will be identified and characterized over the course of infection using flow cytometry and
scRNAseq analysis. In Aim2 we will track the resolution of RAs in the context of high and low inflammatory
environments following infection and in Aim3 we will manipulate RA gene expression to determine the
beneficial and detrimental roles of RAs during chronic Toxoplasma infection. The rationale for the pro-
posed research is that determining the development, function and responsiveness of astrocyte subsets
during chronic infection will provide new knowledge on the long-term consequences of Toxoplasma in-
fection and the basis of a working inflammatory response in the brain.

Public health relevance
Project Narrative On average a third of the world is infected with the protozoan parasite Toxoplasma gondii that causes chronic inflammation in the brain. This proposal will address the activation of CNS resident astrocytes to determine the subsets involved in crucial aspects of neuroinflammation. Knowledge gained from this work will inform not only our understanding of the balance of infection in the brain but also processes that are involved in many neurological neuroinflammatory diseases.